Addressing racial disparities in colorectal cancer risk prediction

PROJECT SUMMARY
With Black men and women experiencing a disproportionately high burden of colorectal cancer (CRC), there is
a critical need for new improved risk prediction tools to identify those at highest risk to undergo screening at
earlier ages or more frequently as needed. Black adults have the highest incidence and mortality rates of any
racial and ethnic group in the US for reasons only partly understood and their risk factors have not been well-
studied to date. Further, Black Americans experience persistently high rates of early-onset CRC diagnosed in
younger adults aged less than 50 years. Early-onset CRC is an emerging public health concern due to rising
incidence rates, leading to a recently reduced routine screening age of 45 years in the US. Established risk
prediction tools such as the NCI's Colorectal Cancer Risk Assessment Tool were developed and validated on
white populations and have been shown to perform poorly in Black women and have not yet been tested in
Black men. In this grant our overarching goal is to develop new personalized CRC risk tools with improved
accuracy that are uniquely tailored for Black Americans, and are built and validated on the data of Black men
and women. Our new web-based risk models will be developed using the rich longitudinal data of large
prospective established US cohorts of Black adults in the Southern Community Cohort Study and Multiethnic
Cohort Study with external validation in three further cohorts of Black adults. Our three aims are: (a) to develop
and externally validate new risk prediction models for colorectal cancer in Black men and women based upon
easily obtainable lifestyle, demographic, social and screening factors; (b) to build dynamic risk models for CRC
for Black adults using modern statistical and machine-learning methods to obtain optimal prediction
performance, and (c) to determine if accounting for the site of the colorectal cancer tumor improves the
individualized prediction accuracy of our new risk models in Black adults. Due to the high CRC incidence and
death rates in Black adults, our new risk prediction models will have significant and far-reaching implications
for colorectal cancer screening and mortality in the Black community. Our new clinical risk tools will provide
accurate personalized risk assessments of CRC which can be used by Black adults and their physicians to
identify those at high risk and to target optimal, timely and effective CRC screening and lifestyle prevention
strategies, leading to earlier detection of CRC, removal of precancerous polyps during colonoscopy and
reduced mortality. Our proposed work closely aligns with current key initiatives of NCI to support research on
improving health equity in cancer.

Public health relevance
PROJECT NARRATIVE Black men and women currently experience the highest rates of colorectal cancer of any racial and ethnic group in the US for reasons only partly understood and their risk factors have not been well-studied to date. Our new web-based decision tools will provide accurate personalized risk assessments of developing colorectal cancer for Black adults, providing clinicians and the Black community with valuable aids to identify those at highest risk for developing colorectal cancer and to inform lifestyle prevention strategies, leading to improved uptake of screening tests and earlier detection of colorectal cancer and lower mortality.